Chronic lung disease phenotyping and genomics in the Veterans Health Administration

Chronic lung diseases (CLDs), including asthma, chronic obstructive pulmonary disease (COPD), and interstitial
lung disease (ILD), cause significant functional limitation and disability and were, collectively, the 4th leading
cause of death in the United States in 2019. Veterans are enriched for environmental exposures which contribute
to the pathogenesis of CLDs (e.g., smoking, environmental toxins) and have a higher burden of CLD relative to
the general population. However, significant heterogeneity in CLD development and progression exists.
Investigations into the genomic contributions towards CLD susceptibility within the Veterans Health
Administration (VHA) have been limited by the lack of robust CLD phenotypes. Key challenges in [clinically-
based] CLD phenotyping include the lack of blood-based biomarkers, variable implementation of diagnostic
testing (e.g., underutilization of spirometry), and inconsistent availability of testing results in the VA electronic
health record (EHR). These barriers result in frequent misclassification and present challenges in identifying
controls as well as cases for large-scale epidemiological and genomic studies.
To address these knowledge gaps, we propose a multi-faceted approach to CLD phenotyping and
validation, followed by genome-wide association studies (GWAS), construction of polygenic risk scores, and
examinations of gene-by-environment interactions including pharmacogenomics within the Million Veteran
Program (MVP). First, we have developed a novel natural language processing (NLP)-boosted EHR-based
phenotyping algorithm which will generate quantitative probabilities for the presence and absence of multiple
CLDs (COPD, emphysema subtype, asthma, interstitial lung abnormalities (ILA), fibrosis subtype) for all VHA
users (~16.8 million) through 2018. Following algorithm optimization and internal validation against 500 gold
standard charts (already adjudicated in duplicate), prospective validation using mortality and respiratory-related
healthcare utilization data collected after 2018 will be performed (Aim 1). Second, we propose independent
phenotyping through quantitative imaging analysis (QIA) of chest computed tomography (CT) data available in
a subset of participants enrolled in MVP (Aim 2). In preliminary work, a secure prototype pipeline behind the VA
firewall for the analysis of archived clinical chest CT data using VA Technical Reference Manual (TRM)-approved
software platforms (3D Slicer, Chest Imaging Platform13,14) has been established. For the current proposal,
through a national network of collaborating VA pulmonary investigators (J. Curtis, VISN10; C. Wendt VISN23;
V. Fan VISN20; C. Wells VISN7; F. Kheradmand, VISN16), full-resolution clinical chest CT data from a subgroup
of individuals enrolled in MVP (n=6,000-9,000) will be analyzed to generate objective, quantitative
measurements of parenchymal lung disease (e.g., percent emphysema and ILA). Each of these QIA-based
phenotypes will be (i) validated against prospective mortality and healthcare utilization outcomes (available from
Aim 1) (ii) utilized as an independent secondary validation of EHR algorithm-derived emphysema, ILA, and
fibrosis (from Aim 1), and (iii) as a distinct, quantitative phenotype in genomic investigations (Aim 3). Third, we
propose to (i) conduct genome-wide association studies (GWAS) within the MVP using EHR-algorithm assigned
CLD case-control status (Aim 1) and QIA-phenotypes (Aim 2), (ii) construct polygenic risk scores (PRS) for each
CLD, and (iii) examine gene-by-environment [and pharmacogenomic] interactions in CLDs (Aim 3). Findings will
be replicated in independent cohorts: International COPD Genetics Consortium (ICGC) and UK Biobank (COPD,
emphysema), Genetic Epidemiology Research in Adult Health (GERA) and Mass General Brigham Biobank
(asthma), and an international cohort investigating idiopathic pulmonary fibrosis (ILA, fibrosis). Upon successful
completion of the project, we will have developed and validated robust phenotypes and identified risk loci for
CLDs which will shed light on disease mechanisms and have the potential to serve as the foundation of
personalized medicine initiatives for CLD management within the VHA.

Public health relevance
Veterans have higher rates of smoking and exposure to inhaled toxins. Veterans also have higher rates of chronic lung diseases, such as asthma, chronic obstructive pulmonary disease (COPD), and interstitial lung disease. However, the risk for developing lung disease is different for every person. Genetic studies may help to us understand risk among Veterans. Genetic studies require large numbers of people with and without chronic lung disease – this has been challenging because tests for diagnosing lung diseases are not always performed, or the information is hard to retrieve. In this project, we use advanced technologies to gather information from the VA’s electronic medical records and new computer programs to analyze chest CAT scans to identify Veterans with and without lung disease. We will then identify differences is genetic markers between Veterans with and without lung disease in the Million Veteran Program. Findings from this study will help us understand risk and develop personalized treatments in the future.